Macrophages as modulators of T cell function and therapeutic response in clear cell renal cell carcinoma

PROJECT SUMMARY/ABSTRACT
The treatment of metastatic clear cell renal cell carcinoma (ccRCC), the most common and lethal form of
renal cell carcinoma, has been revolutionized by therapies directed at vascular endothelial growth factor
(VEGF) and immune checkpoint blockade (ICB) therapies. Despite this progress, the majority of patients
with advanced disease will develop treatment resistance and ultimately succumb to their disease, making
alternative therapeutic strategies a critical need. We have previously demonstrated that ccRCC is highly
immune infiltrated, mostly by T cells and antigen-presenting cells (APCs), in particular, tumor-associated
macrophages (TAMs). We and others have further demonstrated that TAMs are associated with
resistance to both ICB and VEGF-directed therapy, a process thought to be mediated, in part, by T cell
exhaustion. However, TAMs are phenotypically and functionally diverse, and our preliminary evidence
suggests that only some TAM subpopulations are associated with therapeutic resistance. We hypothesize
that specific TAM subpopulations can impact tumor control and response to therapy by presenting antigen
to and influencing T cell phenotype, and therefore that specific inhibition of these TAMs may increase
response to the therapies. To test these ideas, we propose first to finely characterize APC populations in 3
unique sets of human tumors: treatment-naïve, responsive to combination therapy, and resistant to the
therapy. We then assess APC populations as predictors of patient outcome to construct new predictive
models. Next, to uncover how antigen presentation by TAMs locally modulates anti-tumor T cell
responses, we will use a novel genetically faithful, immunocompetent murine model. Specifically, we will
assess immune cell phenotypes and tumor growth in mosaic mice with TAM-specific genetic ablation of
antigen presentation function, as well as assessing TAMs in vitro for ability to present antigen and
influence T cell states. Finally, we will take advantage of indications that various macrophage-directed
drugs in clinical development may selectively inhibit different TAM subsets. After determining which TAM
subpopulations are associated to resistance to current therapies for ccRCC (anti-PD-1, anti-PD-L1, and
the VEGF receptor inhibitor cabozantinib), we will use the mouse model to assess whether resistance can
be overcome by treating with a macrophage-directed drug that inhibits the resistance-associated TAM
subsets. In summary, the proposed research will yield a detailed atlas of APC and T cell states in ccRCC,
a novel model to predict patient outcome, and an understanding of the role of antigen presentation by
TAMs in ccRCC. Further, the proposed research may reveal a means of overcoming resistance to widely
used therapies for ccRCC. Therefore, this work can open the door for precision-based TAM inhibition
strategies to overcome treatment resistance in ccRCC and other immune infiltrated tumors.

Public health relevance
NARRATIVE Although kidney cancers are typically infiltrated with large numbers of the patient's immune cells, these tumors often escape an effective immune response, and many are resistant to immunotherapy. We will test the idea that an effective T cell response to the cancer is inhibited by macrophages (a type of immune cell), driven by a protein called IRF8, and, using novel mouse models of the disease, we will test whether suppressing macrophages can reduce tumor growth and improve responses to therapy. This work may reveal strategies to improve the effectiveness of immunotherapy and combination therapies for patients with kidney cancers.